Data Management and Statistical Core

Data Management and Statistics Core: Summary/Abstract:
The Data Management and Statistics Core
(DMSC) facilitates research and collaborations with local Alzheimer’s disease (AD) researchers, national
initiatives and others by providing high quality data management and methodological support. The University of
Pittsburgh Alzheimer's Disease Research Center (PITT-ADRC) has compiled a database that includes
information collected longitudinally about more than 4700 participants collected over 30 years. The DMSC
works with PITT-ADRC personnel to maximize data completeness and accuracy having developed, and
continuing to maintain and enhance, systems with sophisticated quality control measures for capturing and
computerizing data and for facilitating the work of Core and, ultimately, Developmental project personnel.
Portions of these data are shared with the National Alzheimer’s Coordinating Center and with approved
recipients of PITT-ADRC data. DMSC personnel also support authorized users of the PITT-ADRC database
by preparing reports, creating datasets used for analyses, providing programming and analytical consultation
and support, and serving as Honest Broker to obtain protected data. DMSC personnel are available for
assistance and collaborations concerning data management, study design, study implementation, data
analysis, and data presentation.
To contribute to the educational mission of the PITT-ADRC, and to encourage wider dissemination of PITT-
ADRC data, the DMSC continues to develop the SHared Alzheimer's REgistry (SHARE) dataset that includes
a subset of the extensive data about PITT-ADRC participants and the user-friendly system that allows users
with approved access to query the SQL Server database to facilitate and expand its use.
The DMSC has initiated a Methodology Working Group (MWG) that serves a training mission and provides
a forum for developing and sharing innovative methodologies relevant to AD research. This working group
includes senior-level and early career methodologists, with a broad range of statistical expertise, from across
the University of Pittsburgh who are interested in AD research, several of whom have utilized PITT-ADRC
data. The overarching goal of the MWG is to foster further methodologic work, to expand DMSC abilities to
collaborate with ADRC researchers, and to serve as a hub for training and mentoring the next generation of AD
researchers. The MWG model promotes multidisciplinary research with the capability to further our
understanding of AD etiology and pathogenesis to help drive the development of effective therapies.